PRODUCTION ASSISTANCE FOR CELLULAR THERAPIES (PACT)- CELL PROCESSING FACILITIES CELL MANUFACTURING AND PROCESS DEVELOPMENT SERVICES FOR PCT004-01A: PRODUCT IPSC DERIVED- CPC FOR PORCINE STUDIES

The goal of this task order is to use cells developed by PACT to perform a placebo controlled, preclinical dose response study to assess safety and compare the efficacy of iPSC-CPCs to the contractor’s current MSC approach. This IND enabling study will be the basis for determining the initial dose(s) for the Phase I/II clinical trial.